Mechanisms of Lymphomagenesis of Skin Resident Gamma Delta T cells

PROJECT SUMMARY
Primary cutaneous gamma delta T cell lymphomas (PCGDTLs) are a collection of highly aggressive, incurable
non-Hodgkin lymphoma of the skin-homing γδ T cell. Median survival is 31 months. Five-year survival is 19.9%.
Without a fundamental understanding of disease pathophysiology, there has been little progress in the last few
decades. A critical unmet need is to uncover novel therapeutic targets via elucidation of basic disease
mechanisms. Lymphoma phenotypes are determined by a combination of somatic mutations and cell of origin.
To elucidate the genomic, transcriptional, and cellular origins of PCGDTLs, we have assembled a large, multi-
institutional cohort of samples representing diverse clinical phenotypes. By analyzing high-dimensional genomic
and immunological data, we hypothesize that we can identify the molecular basis of this disease. Importantly,
these studies represent a serendipitous opportunity to elucidate the biology of skin-resident gamma delta T cells,
a poorly understood but likely important lymphocyte in human skin.

Public health relevance
PROJECT NARRATIVE We propose to study a large, multi-institutional cohort of gamma delta T cell lymphomas to identify the biological basis of this disease.